CORE--CELL ISOLATION AND CULTURE

The majority of the projects will use experimental preparations that require isolation and characterization of adult and neonatal cardiac muscle cells, or cardiocytes. This core will isolate cardiocytes from: 1) the adult cat, 2) the adult mouse, and 3) the neonatal rat. Adult cardiocytes will be isolated from both normal hearts and surgical models of pressure overload hypertrophy. Additionally, Project #4 will utilize mouse C2/C12 skeletal muscle cell lines. These demands will best be met by a Core Facility where supply purchases, reagent preparation, and routine procedures can be performed with an economy based on scale, with quality control monitored from a centralized, experienced authority, and time saved by providing labor-intensive services in a centralized facility.